A PHASE I STUDY OF IDURD AS A RADIOSENSITIZER IN LOCALLY ADVANCED CERVIX CANCER

This protocol has recently opened. Seven patients have been treated. There have been no unexpected acute toxicities. A flyer is being sent out improve accrual.